The purpose of this procurement is to provide strategic planning and support service for the NCI CBITT

The purpose of this procurement is to provide strategic planning and support service for the NCI CBITT